Bioethics research to understand engagement in decision-making among adolescents and young adults with cancer at risk for health care disparities

ABSTRACT
This application for an administrative supplement responds to NOSI NOT-OD-25-015: Research and Capacity
Building Efforts Related to Bioethical Issues. This proposal plans bioethics research to examine adolescent and
young adult (AYA, age 12-29) engagement in decision-making about cancer treatment. The proposal builds on
our funded R01, now in year 2, which is designed to evaluate disparities in clinical trial enrollment among AYAs
with cancer. The study is being conducted in 3 states, Louisiana, New Mexico, and Tennessee, each of which
has a racially, ethnically, socioeconomically, and geographically diverse population. We will leverage the data
and infrastructure of the funded R01 to more deeply understand treatment decision-making among AYAs with
cancer. Engagement in medical decisions fulfills bioethical principles of autonomy, and our prior work has found
that AYAs across the age range express a desire to participate in decisions about their own care. Yet many
AYAs report being inadequately engaged in medical decisions. In our prior work, we have identified three main
factors that support engagement in decision-making among AYAs: information, voice, and support. AYAs require
information about treatment options and possible outcomes; need opportunity to voice their personal
preferences, goals, and concerns about treatment; and desire the support of trusted others, such as family
members and clinicians, as they make decisions. Together, information, voice, and support allow AYAs to
engage in decisions in the way they choose, holding autonomy to the extent desired but also experiencing
support and advice from those they trust. The proposed study will allow us to examine these three key attributes
of decisional engagement among AYAs with cancer, including differences across a racially and ethnically diverse
population, whose needs and experiences with decisional engagement have received limited attention in prior
research. We will augment measures and analyses from planned surveys and audiotaped informed consent
conversations in the funded R01 in order to answer these fundamental bioethical questions relevant to AYAs
with cancer. Aim 1 will use surveys of 200 AYAs to assess the quality of decisional engagement, defined as
information, voice, and support, among AYAs with cancer, including differences in engagement by age, race,
and ethnicity. Aim 2 will examine interpersonal dynamics of clinical trial conversations with AYAs, drawing on
rich data from audiotaped and observed informed consent conversations as well as in depth interviews. The
proposed bioethics research supplement will efficiently augment planned data collection in the funded R01 to
study decisional engagement, a significant bioethical issue pertinent to AYAs. At the end of this study, we will
have assessed the quality of engagement in decision-making across a diverse cohort of AYAs and identified
interpersonal dynamics that allow AYAs to feel that their voices are heard. These data will support future work
to enhance decisional engagement across a diverse population.

Public health relevance
PROJECT NARRATIVE Adolescents and young adults (AYAs, age 12-29) across the age range express a desire to participate in decisions about their own care, yet many AYAs report being inadequately engaged in medical decisions. The proposed bioethics research supplement will leverage the existing infrastructure and data collection from our funded R01 to assess decisional engagement among AYAs with cancer, with consideration of the needs of a racially and ethnically diverse population. The goals of this study are to understand the quality of engagement of AYAs in treatment decisions, including differences by age, race, and ethnicity, and to understand interpersonal dynamics of treatment decisions that involve AYAs, with an eye toward developing interventions to meet the needs of AYAs.